Defining Genome Stability Mechanisms and their Regulation by SUMO and Ubiquitin

Maintaining genetic integrity is crucial for cell viability and disease suppression. Consequently, cellular
machinery such as the DNA damage response (DDR) has evolved to combat continual genotoxic insults.
Whilst specific DNA repair mechanisms have been defined in great detail, understanding the spatiotemporal
regulation of DDR factors in the cell remains a key challenge. Here, the covalent postranslational modifiers
(PTMs) SUMO and ubiquitin play critical roles, both recruiting DDR proteins to DNA lesions, and then removing
them as necessary to promote repair. Indeed, defects in the SUMO and ubiquitin pathways cause failed DDR
orchestration, severe genetic instability, and disease. Therefore, the overarching goal of our research is to
delineate SUMO and ubiquitin mediated mechanisms that maintain genome integrity, with an eye to identifying
and exploiting potential therapeutic avenues. Our proposal centers on two factors, STUbL and SMC5/6, which
integrate signaling through SUMO and ubiquitin to support key health-related processes. Of note, STUbL
mediates the therapeutic effects of arsenic trioxide in leukemia, and SMC5/6 mutations cause severe disease.
STUbL is an E3 ubiquitin ligase that selectively recognizes and ubiquitinates SUMOylated proteins to promote
their degradation and/or extraction from chromatin. SMC5/6 is functionally related to cohesin and condensin
but uniquely, can modify targets with SUMO and ubiquitin. To provide functional insights, we used proximity
labeling to reliably map the proteomic environments of STUbL and SMC5/6 in key health-related settings such
as: dysfunctional telomeres, DNA repair, and viral replication. Surprisingly, considerable overlap was identified
between each proteome, creating further synergy and efficiency in our research. For example, the functions
and targets of SMC5/6 and STUbL intersect in the “alternative lengthening of telomeres” (ALT) pathway used
in ~15% of cancers. Thus, we would define STUbL and SMC5/6 roles in the elongation and “trimming” of
telomeres through the novel ALT-specific targets and cofactors we identified. In addition, a wealth of recent
data supports our hypothesis that STUbL controls SUMO pathway homeostasis, as well as specific targets, to
support genome stability, DNA replication, and cell survival. Further analysis using genetic manipulation of the
SUMO pathway (e.g. CRISPR/Cas9), mediators of SUMO chain toxicity, and new STUbL targets would
establish this key paradigm in SUMO and ubiquitin pathway crosstalk. We also recently identified an SMC5/6
cofactor that binds SUMO and directs the complex to phase-separated ALT PML nuclear bodies, sites of viral
replication, and likely DNA lesions, thereby unifying these seemingly disparate processes. Hence, we would
define functions for SMC5/6 and its new SUMO binding cofactor in each of these processes to reveal common
mechanisms. Overall, our collaborative teams' analysis of STUbL and SMC5/6 using proteomic, genetic, cell
biological, biochemical, and biophysical methods would synergize to define key health-related mechanisms at
the nexus of the SUMO and ubiquitin pathways; providing targets and guidance for therapeutic interventions.

Public health relevance
To develop effective preventative and therapeutic strategies it is vital that we define the cellular pathways and mechanisms that suppress diseases such as cancer. In this proposal we would determine how two small but potent proteins called SUMO and ubiquitin collaborate to orchestrate the cells' genome stability machinery, which includes DNA repair proteins. Vitally, apart from the much-needed fundamental knowledge we would gain, the SUMO and ubiquitin pathways offer therapeutic possibilities that our analyses would help exploit.